IGF::OT::IGF OMICS IN LATINOS - GENETIC ANALYSIS (OLGA)

Examine: 1) Genome-wide association analysis for periodontal disease, including covariates such as age, gender, and race/ethnicity; papers proposals generated by HCHS/SOL working groups; 2) Gene-environment interaction in periodontal disease for 2-3 established risk factors, such as tobacco use and diabetes; 3) Genome-wide association analysis for dental caries, including covariates such as age, gender and race/ethnicity, and 4) Gene-environment interaction in dental caries for 2-3 established risk factors such as sugar intake or oral hygiene practices.